Accelerating Public Health Impact Through the University of Washington/NASTAD Research Alliance in Implementation Science to End HIV (RAISE) Regional Consultative Hub

ABSTRACT
The Ending the HIV Epidemic (EHE) Initiative has an ambitious goal of a 75% reduction in new HIV infections
in the US by 2025, and a 90% reduction by 2030. To meet these targets, progress will be required across all four
EHE pillars (diagnosis, treatment, prevention, and response), and across all 57 Phase I EHE jurisdictions.
Implementation science, with a focus on improving the delivery of evidence-based interventions at scale, has
the potential to catalyze EHE investments by identifying how to deliver interventions and contribute to the EHE
targets. The Research Alliance in Implementation Science to End HIV (RAISE) Regional Consultative Hub (RCH)
was founded in 2022 with supplemental EHE funding to the University of Washington/Fred Hutch Center for
AIDS Research with the objective of maximizing the impact EHE investments through the support of EHE-funded
implementation science efforts in priority jurisdictions. Our application leverages the depth and breadth of
implementation science capabilities and training opportunities at the University of Washington and the National
Alliance of State and Territorial AIDS Directors (NASTAD). The RAISE team is ideally situated to continue to link
implementation science research with public health programs to enhance the impact of EHE. Our faculty is at
the forefront in defining multidisciplinary, implementation science research methods, and has developed novel
training curricula in public health and implementation science. Furthermore, RAISE-affiliated investigators lead
diverse programs to implement and scale-up HIV prevention and treatment interventions that have developed
strong, collaborative relationships with health departments throughout the U.S. Our proposed activities are
designed to enhance the impact of EHE investments through building timely and appropriate implementation
science capacity, fostering academic-public health collaborations, developing generalizable knowledge on
effective implementation strategies, and meeting EHE reporting requirements. The RAISE hub proposes three
aims to achieve the project goals. First, to provide implementation science consultation services to select NIH-
supported EHE research projects and support these projects to meet funding reporting requirements, develop
effective dissemination strategies, and foster cross-site research opportunities. This aim will leverage our
implementation science expertise and existing training curricula in study designs; selection and development of
implementation strategies; implementation science theories, models and frameworks; implementation outcome
selection and deployment; economic evaluations; and health department/academic research partnership
development. Second, in conjunction with NASTAD, to strengthen and expand the RAISE implementation
science learning platform that links health departments with implementation researchers to foster relevant and
robust research that is responsive to health department needs and enhances the impact of their implementation
efforts. Third, also in conjunction with NASTAD, foster improved implementation of local HIV treatment services
in EHE jurisdictions through the establishment of two 18-month learning collaboratives.

Public health relevance
PROJECT NARRATIVE The Ending the HIV Epidemic (EHE) Initiative brings significant resources to 57 priority jurisdictions, with the goal of a 75% decrease in new HIV infections in the US by 2025, and a 90% reduction by 2030. Implementation science contributes to these goals by building an evidence base on how to best deliver evidence-based interventions that prevent HIV infections. This application proposes to continue the Research Alliance in Implementation Science to End HIV (RAISE) Regional Consultative Hub that was founded in 2022 through supplemental funding to the University of Washington/Fred Hutch Center for AIDS Research to provide implementation science expertise and resources, catalyze the impact of EHE implementation research efforts, and broaden a health-department focused implementation science platform to strengthen local EHE activities.